AIDS Linked to the IntraVenous Experience (ALIVE)

ABSTRACT
In this competing renewal, we propose to continue a 30-year cohort of people who inject drugs (PWID). Since
1988, the AIDS Linked to the IntraVenous Experience (ALIVE) study has followed >5200 PWID in a
community-based cohort in Baltimore, MD, providing critical insight into the natural and treated course of HIV
among urban predominantly minority, disadvantaged PWID. Our team has been highly productive (107
publications in past cycle) and will continue cutting-edge investigations into high HIV/AIDS priority research
questions, while serving as a foundation for an array of HIV-related epidemiological and pathogenesis studies.
The opioid crisis across the US continues and has not abated in Baltimore. Baltimore has one of the highest
US overdose rates and is experiencing demographic and behavioral transitions in the population most affected
by opioid use -- from one that is primarily male, older and minority -- to one that affects more women, younger
and white individuals. At the same time, there has also been a shift in the expression of HIV infection among
PWID. Much of the population of PWID that the ALIVE study has traditionally followed is aging into the decade
of life where HIV and its treatment are complicated by the onset of other chronic age-associated health
conditions; in 2016, 40% of our cohort had >2 non-communicable diseases (NCD). At the same time <50% of
our HIV-positive participants currently have suppressed HIV viral load highlighting a need for a more holistic
approach to HIV care one that more broadly incorporates NCDs. Our proposed continuation will address the
spectrum of the intersecting HIV and opioid epidemics with an eye towards understanding the impact of opioid
use and HIV across the PWID life course. Our Specific Aims are: 1) To monitor temporal trends in the opioid
epidemic comparing HIV infected and uninfected PWID across the lifespan, including characterization of
shifting drug profiles and context over time and their impact on the incidence of fatal and non-fatal overdose,
HIV and HCV infection and mortality. 2) To evaluate the dynamic associations between HIV care continuum
outcomes and prevalence and control of NCDs (e.g., diabetes, hypertension, hyperlipidemia, chronic
obstructive pulmonary disease [COPD]) and their joint impact on morbidity, mortality and quality of life; and 3)
To continue to provide a platform for independently-funded investigations of HIV and drug use. To achieve
these aims, we will 1) continue follow-up of HIV positive and negative PWID (~1500); 2) open recruitment
once; and 3) evolve our data collection methods to include novel field-based, mHealth and drug testing
assessments. The ALIVE cohort is unique in that it comprises a community-based PWID population of both
genders with significant representation of African-Americans who are both in and out of medical care; these
populations have been underrepresented in HIV and drug use research. Given the scientific rigor of the
proposed methods, existing infrastructure, experienced investigators and multiple NIH-funded ancillary studies,
we anticipate continued success and substantial scientific impact in the future.
!

Public health relevance
PROJECT NARRATIVE Many urban settings including Baltimore face dual opioid and HIV epidemics, one among older predominantly minority PWID who are disproportionately affected with HIV, and an emerging epidemic among younger white individuals living in suburban Baltimore who are at high risk for HIV. The findings from this study will inform both interventions targeting new PWID populations at risk for HIV as well as programs to optimize engagement of PWID in care and treatment for not only for HIV but for non-communicable diseases which will improve overall health and well-being.